GENOMICS OF BRAIN STRUCTURE AND FUNCTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project aims to assess and characterize potential genetic contributions to human brain structure and function. This is an umbrella protocol and it is designed to consent subjects who are already recruited to neuroimaging protocols to provide a blood sample for genetic analysis and storage. Therefore the protocol does not have a targeted enrollment. Participants in this protocol are the subjects recruited to other protocols who agree to provide their DNA for the purpose of genomic analysis in conjunction with their neuroimaging and behavioral data derived from the original protocol for which they initially consented. This protocol was conceived based on the hypothesis that the common variations of certain genes contribute to variability in brain structure and function.